Personalized Anesthesia: The Role of the Locus Coeruleus in Individual Anesthetic Responses

PROJECT SUMMARY/ABSTRACT
Millions of patients are placed into a reversible state of unconsciousness by anesthesiologists for life saving
surgeries every year. The basic goals of anesthetic care are to reliably extinguish consciousness for the
duration of surgery and afterwards swiftly return the patient to their baseline cognitive state. Neither one of
these goals can be reliably achieved today, however. Some patients regain consciousness during surgery.
Episodes of consciousness are not reliably detected by current intraoperative EEG-based monitoring and can
result in post-traumatic stress and anxiety disorders. In contrast, other patients take a long time to resume
normal cognition. This can manifest as postoperative delirium and cognitive derangements. Postoperative
delirium affects millions of patients, costs 34 billion dollars annually, and can itself be a harbinger of cognitive
dcline after surgery. Such persistent decrements in cognitive function can last for many months. It is presently
unclear why some patients experience peri-anesthetic complications while other patients that receive
seemingly identical anesthetics have an uneventful perioperative course. To address this, we propose to
study individual-based anesthetic pharmacology rather than previously used population-based measures.
We have recently developed experimental and computational methods to quantify individual-based
measures of anesthetic responses in mice. The use of these methods revealed that conventional
population-based pharmacological concepts such as drug potency are not sufficient to describe individual
responses. We identified two independent measures that do capture the range of individual responses:
sensitivity and resistance to state transitions (Rst). Sensitivity describes how often an individual is awake or
anesthetized at an anesthetic dose, while Rst describes how frequently transitions happen between those two
states. We demonstrated that sensitivity and Rst can be differentially pharmacologically modulated. We also
demonstrated that chemogenetic activation of an arousal pathway – locus coeruleus – decreases Rst without a
change in drug sensitivity. Because Rst is completely obscured in population-based pharmacological studies,
we hypothesize that Rst is the “hidden variable” that may help explain why some patients experience
peri-anesthetic complications while others do not.
We propose to investigate the mechanisms through which the locus coeruleus decreases Rst. Using
pharmacologic and genetic approaches, we will identify the neurotransmitter systems used by the locus
coeruleus to modulate Rst. Separately, we will identify the effects of the locus coeruleus on neurophysiologic
state change, including correlates of behavioral Rst, using a high-density EEG system developed by our lab.
Finally, we will turn towards identifying the neuronal pathways through which locus coeruleus acts to modulate
Rst. The proposed lines of investigation will clarify how activity of the locus coeruleus influences individualized
anesthetic responses, and will be an important step towards delivering personalized anesthesia.

Public health relevance
PROJECT NARRATIVE For the tens of millions of patients who receive general anesthesia every year, it is still unclear why some patients experience peri-anesthetic complications while other patients that receive seemingly identical anesthetics have an uneventful perioperative course. In order to be able to tailor an anesthetic to the needs of an individual patient, we plan to investigate individualized measures of response to anesthetics, and the neural pathways that can affect those individual differences. We propose to investigate how the major adrenergic center of the brain, the locus coeruleus, changes one of those individualized measures, how stable a patient is in the awake or anesthetized state.